Mechanical and Metabolic Pathways Underlying MYBPC3 Hypertrophic Cardiomyopathy

PROJECT SUMMARY/ABSTRACT
Candidate: Joshua Meisner, MD, PhD is a pediatric cardiologist and physician-scientist focused on
understanding the molecular basis of and developing translational therapeutic approaches for pediatric-onset
cardiomyopathies. His long-term career objective is to become an independent investigator integrating the
biomechanics and metabolism of pediatric-onset cardiomyopathy.
Research Context: Truncating variants of myosin-binding protein-C, cardiac type (MYBPC3), are the most
common cause of hypertrophic cardiomyopathy (HCM), a leading cause of sudden death and heart failure. The
most severe cases of HCM develop substantial hypertrophy during childhood and adolescence. HCM disease
progression is proposed to be primarily driven by mechanical and energetic stress from dysregulated
myocardial workload. This leads to hypertrophy, fibrosis, and metabolic dysregulation. However,
pathophysiology and disease progression in MYBPC3-related HCM remains unclear due to lack of in vivo and
in vitro models that replicate human disease. Consequently, the pre-clinical testing of emerging therapeutics is
severely limited. To solve this problem, Dr. Meisner developed novel models in both induced pluripotent stem
cell cardiomyocytes (iPSC-CMs) and mice that replicate severe, adolescent-onset MYBPC3-related HCM.
Specific Aims: Using these two systems, Dr. Meisner aims to elucidate the role of energetic and mechanical
stress in MYBCP3-related HCM progression and test for reversibility in early and late stage HCM. In Aim 1, he
will establish the time course of hypertrophy, metabolic dysregulation, and fibroblast activation in his MYBPC3-
related HCM mouse model. Then, he will test the reversibility of pathology by independent targeting
hypercontractility and mitochondrial dysfunction. In Aim 2, using iPSC-derived cardiac tissues under highly
controlled biomechanical conditions, he will determine the acute effects of increased mechanical stress and
energetic stress on metabolic dysfunction and fibroblast activation with loss of MYBPC3.
Career Development Plan: To achieve his long-term career goals, Dr. Meisner has developed a detailed
training plan focused on four areas: 1) cardiac metabolism, 2) bioengineering approaches to modulate tensile
stress and workload in cardiac tissues, 3) in vivo drug testing and phenotyping, and 4) high-throughput
bioinformatics analysis including snRNA-seq approaches to quantify cardiomyocyte- and fibroblast-specific
transcriptional changes during disease progression. A five-year plan encompassing selected coursework and
project-based mentoring will equip Dr. Meisner with a unique skill set applicable to the study of a broad range
of pediatric onset cardiomyopathies. His career development and transition to independence will be supported
by close mentorship from an interdisciplinary team with expertise in each scientific training objective.
Environment: The University of Michigan offers the ideal environment for Dr. Meisner to pursue this training,
with the outstanding guidance of well-established mentors dedicated to his success.

Public health relevance
PROJECT NARRATIVE Hypertrophic cardiomyopathy (HCM) affects about 1 in 500 people, with variants of the myosin-binding protein- C, cardiac-type (MYBPC3), being the most common genetic cause. MYBPC3-related HCM is characterized by disordered heart contraction, cardiac hypertrophy, fibrosis, and metabolic dysfunction, but effective interventions are unclear due to limited understanding of disease progression and mechanisms. The overarching goal of this proposal is to determine how contractile and metabolic stress drive HCM progression and test whether targeted contractile and metabolic interventions can prevent or reverse disease.